Assessing the effects of a multisectoral agricultural intervention on the reproductive and sexual health of adolescent girls and young women

ABSTRACT
In Kenya, HIV incidence among adolescent girls and young women (AGYW) ages 15-24 years is 1-2 per 100
person-years and approximately 30% of AGYW have had at least one sexually transmitted infection (STI).
Kisumu, Homa Bay, and Migori counties in Western Kenya have the highest HIV/STI incidence in the country.
Food insecurity (FI) and poverty are also highly prevalent in Western Kenya, due in part to extreme weather
events and climate disasters. FI and poverty are important drivers of vulnerability to HIV and STIs among AGYW.
Poverty alleviation interventions have the potential to reduce STIs and HIV risk among AGYW but, to date, these
interventions have reported mixed findings on HIV/STI outcomes, have been primarily targeted at the individual
level, and none have focused on agriculture or FI. Therefore, there remains a critical need to develop sustainable,
multi-level, economic and FI interventions that improve AGYW STI/HIV prevention outcomes. Our team has
successfully developed a climate-adaptive, household-level agricultural intervention in Western Kenya called
Shamba Maisha (“farm life” in Kiswahili; SM) to reduce household FI. In our prior pilot study with AGYW, we
found that SM was feasible, acceptable, and associated with less FI and improved mental health. In this proposal,
we will build upon our promising SM work by examining the effectiveness and implementation of our SM
intervention, including provision of a water pump and agricultural implements for use at home, training in climate-
adaptive farming agriculture delivered at school-based demonstration farms, and adolescent-caregiver
relationship strengthening training. We plan to conduct this school- and home-based cluster randomized trial
with 800 AGYW and their primary caregivers recruited from schools in Kisumu, Homa Bay, and Migori counties.
We will randomize 20 schools in Western Kenya to intervention or control conditions and follow AGYW-caregiver
dyads for 18 months with surveys and STI/pregnancy testing to assess intervention impacts. In Aim 1, we will
determine the impact of SM on adolescent HIV prevention and sexual and reproductive health outcomes (primary
outcome is gonorrhea and/or chlamydia incidence). In Aim 2, we will assess the effect of SM on intermediate
outcomes theorized from our published conceptual framework to be on the causal pathway, including household
food security and wealth, and adolescent and caregiver factors including mental health and aspects of the
caregiver-AGYW relationship dyad (e.g., communication). In Aim 3, we will identify critical implementation
facilitators and barriers influencing SM effectiveness and delivery and conduct a programmatic cost assessment.
We will also evaluate the extent to which SM can have “spillover” nutritional benefits for a larger population of
adolescents who had access to demonstration farms at intervention schools but did not receive other aspects of
the intervention. Our ultimate goal is to provide an innovative household-level, climate-adaptive intervention to
halt the cycle of extreme weather events, FI, and poor HIV-related outcomes among vulnerable populations
including AGYW, consistent with the “Ending the HIV Epidemic” and Sustainable Development Goals.

Public health relevance
Project Narrative/Public Health Relevance Statement The incidence of HIV and sexually transmitted infections (STIs) remains high among adolescent girls and young women (AGYW) in Western Kenya, driven by upstream structural factors like food insecurity (Fl) and poverty. Our multi-disciplinary team proposes to conduct a cluster randomized controlled trial among 800 AGYW-caregivers dyads in Western Kenya to test the impact of our innovative school- and household-based Shamba Maisha intervention package (with agricultural commodities, training in sustainable farming practices at school-based demonstration farms, and caregiver-adolescent relationship strengthening training) on STI and HIV prevention outcomes. This rigorous study may provide a model for a multi-pronged approach to halt the cycle of Fl, and poor HIV-related outcomes among AGYW, in line with NIH priority for HIV health research.